Life Course Center for the Demography and Economics of Aging

Project Summary/Abstract
The Life Course Center (LCC) at the University of Minnesota is an emerging incubator for innovative research
on the demography and economics of aging. As an NIA-supported University-wide cooperative, LCC will recruit
and foster connections among researchers across disciplines; develop leading-edge collaborative pilot studies
on aging contexts, trends, dynamics, and disparities; provide technical and administrative support for research
development; and develop a research network to leverage large-scale population data to advance
interdisciplinary scholarship on social determinants and contexts of aging and health. Over the next five years,
we will focus on three research themes that are crucial to understanding the demography and economics of our
aging society. These themes leverage our intellectual strengths and unique resources: (1) Later Life-Course
Population Trends in Context: Determinants within and across space, time, and social location of population
trends at older ages in physical and cognitive functioning (including AD/ADRD), disability, morbidity, mortality,
health and well-being.
(2) Life-Course Dynamics as Disparity Mechanisms: How life-course pathways foster
disparities in healthy aging, including protective factors (e.g., social engagement and support, income adequacy,
positive early determinants, and health behaviors).
(3) Interrelationships of Work, Family, Community
Participation, and Health: Consequences of later life work, family and community participation for health
outcomes of older workers and retirees. We will establish three infrastructure cores to overcome key barriers to
path-breaking research: Core A: Administrative and Research Support Core. This Core will provide leadership
and vision, as well as logistical support and oversight for the activities of the other two Cores. This Core will also
be responsible for meeting all reporting requirements to the Coordinating Center. Core B: Program Development
Core. LCC will support small-scale, innovative interdisciplinary research projects. The Core will annually fund
four to six outstanding pilot projects proposed by LCC members and from members of the External Innovative
Network Core. The proposed pilot program will prioritize support of early career investigators as well as
investigators from historically underrepresented groups. Core C: External Innovative Network Core. The Network
will foster an interdisciplinary community of researchers focusing on the demography and economics of aging
who will share knowledge and resources for using big population data and for applying a life-course perspective
to aging research. The Network Core will address challenges associated with big population data, prospective
longitudinal data based on record linkage, and restricted access data.

Public health relevance
Narrative Developing policies and practices that maximize later life-course health and well-being while minimizing disparities across population subgroups requires understanding the social determinants of physical, emotional, cognitive, and economic health. The Life Course Center (LCC) at the University of Minnesota provides the theoretical frameworks and outstanding research infrastructure—including access to innovative sources of population data—needed to address these crucial issues. The Center facilitates interdisciplinary collaborations to directly addresses Goal E of NIA’s Strategic Directions (2016): to “improve our understanding of the consequences of an aging society to inform intervention development and policy decisions”